Autophagy and its Regulation in Diabetic Embryopathy

SARS-CoV-2 infection induces activation of ferroptosis in the placenta
Summary
Pregnancy is a risk factor for SARS-CoV-2 infection and worse COVID-19 outcomes. Therefore, there is an
urgent need for research into underlying mechanisms leading to the pathogenesis of adverse pregnancy
outcomes and the development of optimal COVID-19 treatment during pregnancy. Most adverse pregnancy
outcomes are of placental origin because the human placenta can synthesize many hormones and cytokines to
influence ovarian, uterine, mammary, and fetal physiology. Recent advances in understanding cell death
mechanisms in cell death mechanisms have led to significant recognition of the role of ferroptosis in regulating
cell fate. As a form of nonapoptotic programmed cell death, ferroptosis is characterized by redox-active iron-
dependent hydroxy-peroxidation of polyunsaturated fatty acid-containing phospholipids and compromised lipid
peroxidation repair capacity. Because dysregulation of iron metabolism plays has been shown to play an
important role in the etiology of COVID-19, the central hypothesis of this study is that SARS-CoV-2 infection
leads to activation of the ferroptosis process in the placenta, thereby serving as a pivotal contributor to
dysregulation of placental function and subsequently pathogenesis of adverse pregnancy outcomes.
We plan to pursue two Aims. Aim 1. To determine gene expression levels of hallmarks of ferroptosis in
SARS-CoV-2-infected human primary placental tissues and trophoblastic cells. A number of studies have
shown increased COVID-19 risk among pregnant women experiencing obstetrical complications. While multiple
underlying signaling pathways may associate these two events, we hypothesize that ferroptosis is primarily
responsible. Aim 2. To recapitulate SARS-CoV-2 infection-induced activation of the ferroptosis process
in the placenta in vitro. We will use human primary placental cytotrophoblast as an in vitro model to accomplish
this Aim. This research is significant because it addresses a fundamental question regarding mechanisms
underlying correlation of COVID-19 and pathogenesis of adverse clinical outcomes. Furthermore, this study
explores a novel concept: ferroptosis signaling can serve as such a mechanism, thus facilitating development of
new and effective therapeutic approaches for treatment of these complications.

Public health relevance
PROJECT NARRATIVE The proposed research is significantly relevant to public health because the discovery of the mechanisms leading to SARS-CoV-2 infection-associated adverse pregnancy outcomes (APOs) will ultimately allow development of effective therapeutic intervention approaches. Therefore, our proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge to reduce detrimental obstetrical outcomes because of this viral infection.